The Influence of Aerodynamic Particle Size on the Virulence of Aerosolized Ebola Virus

The goal of this project is to examine the influence of aerodynamic particle size on the median lethal dose and disease presentation in a nonhuman primate model of inhalational Ebola virus disease (EVD).